Novel Function(s) of Arenavirus NP Exoribonuclease

PROJECT SUMMARY/ABSTRACT
Several mammalian arenaviruses cause severe and fatal zoonotic diseases in humans, for which vaccines and
treatments are very limited. Lassa virus (LASV) is the causative agent for Lassa fever (LF) that is currently
endemic in Western Africa. Despite its importance to public health, important knowledge gaps still exist in the
basic biology for LASV and other highly pathogenic arenaviruses, partly due to the limitation of high containment
BSL4 facilities required for infection experiments. The RNA synthesis of RNA virus is generally error prone as
viral RNA-dependent RNA polymerase lacks proofreading activity. As negative-sense RNA virus, how arenavirus
ensures proper RNA synthesis is largely unclear. The LASV nucleoprotein has a DEDDH 3' to 5' exoribonuclease
motif (ExoN), of which its function in virus life cycle is still a puzzle. The current paradigm in the field is that the
NP ExoN activity efficaciously degrades virus-derived double-stranded RNA and is the key to LASV evasion of
innate immunity. Intriguingly, the ExoN motif is highly conserved in NPs of all arenaviruses, regardless of
pathogenicity. Therefore, it is very likely that the NP ExoN has important but yet-to-be-identified function(s) in
arenavirus replication in addition to immune evasion. In this project, we aim to define the important role(s) of
arenavirus NP ExoN in virus replication.
Our preliminary data indicated that: 1). Loss of NP ExoN activity resulted in aberrant genomic RNA production
and a drastic reduction in LASV RNA level in IFN-deficient cells; and 2). Loss of NP ExoN activity increased
LASV sensitivity to mutagenic nucleoside analogue treatment. We propose that LASV NP ExoN promotes proper
viral RNA synthesis, controls aberrant viral genomic RNA formation and/or ensures the fidelity of viral RNA
replication. To define the impact of NP ExoN on the integrity and functionality of viral genomic RNA, we will
explore to utilize an innovative long-read sequencing technology to systematically investigate the sequence and
abundancy of genomic RNAs at single molecule level. Arenavirus has been known to form defective interfering
particles, which regulates virus infection in vivo and in vitro. The molecular basis for DI genome remains elusive
due to technical obstacle. The long-read sequencing technology may enable us to identify DI candidates and the
potential role of NP ExoN in regulating DI formation. We will also investigate whether arenavirus NP ExoN has
proofreading activity that ensures the fidelity of viral RNA replication.
At the end of this project, we may discover novel and important function(s) of arenavirus NP ExoN in virus life
cycle and move the field forward. Using LASV as a model, we may better understand how arenavirus virus
ensures proper viral RNA synthesis. With the novel long-read sequencing technology, this study may overcome
technical barrier and increase our knowledge on basic virology of pathogenic arenaviruses. The data may open
up new directions. For instance, future studies on the mechanisms underlying the important roles of NP ExoN
are warranted. This project may also facilitate antiviral development by targeting NP ExoN activity.

Public health relevance
PROJECT NARRATIVE The arenavirus family includes the Old World Lassa virus (LASV) and the New World Junín virus and Machupo virus that cause severe and fatal zoonotic diseases, for which vaccines and treatments are very limited. A 3' to 5' exoribonuclease motif (ExoN) is highly conserved in the nucleoprotein of mammalian arenaviruses, which mediates degradation of virus-derived dsRNA and is crucial for LASV evasion of host innate immunity. In this study, we would define novel and important function(s) of NP ExoN in LASV replication, which may increase our basic knowledge on the function of arenavirus NP and inform antiviral development.